Harnessing protein clustering to understand, identify, and manipulate cellular systems

Summary/Abstract
The Bugaj Lab develops precision-controlled molecular tools to better understand and control biological
systems. This proposal will develop technologies that harness protein clustering for new, enabling methods to
study, manipulate, and treat cells. Protein clustering plays important roles throughout cell physiology and
disease, yet its potential for biotechnological probes and therapies remains unrealized. Clustering is potent
because it achieves rapid and non-linear responses with minimal energetic costs. Over the past decade,
optogenetic clustering probes have allowed control over protein clustering with high precision throughout a
wide array of cellular processes. However, despite the high utility of optogenetic clustering, there remains
predominantly one protein (A. thaliana Cry2) whose light-induced clustering is used for such probes,
constraining its application due to inherent limitations, for example response time and ability to control one
process at a time. Our first project will address these technological gaps by engineering a distinct
photoreceptor that we recently discovered possesses a native ability to form light-induced clusters in
mammalian cells, providing a complement to Cry2 with certain favorable properties, including in response
kinetics. In our second project, we will develop a suite of single-component optogenetic probes that allow
precise control of subcellular localization to a variety of compartments. These probes uniquely harness the
ability of clustering to trigger binding through rapid increases in probe avidity. In our third project, we will
develop the foundations of synthetic protein therapies that can sense and respond to endogenous protein
clusters. Clustering is a hallmark of many pathologies including neurodegeneration, viral infection, and cancer,
and thus protein clustering itself could be leveraged as a disease biomarker or therapeutic target. We will
engineer autonomous protein systems that detect pathological protein aggregates and execute a strong,
appropriate response, for instance killing a cancer cell or secreting cytokines to recruit the immune system.
Successful completion of our work will establish protein clustering as a flexible new paradigm for manipulation
of cellular function, resulting in broadly applicable probes for study of cell/animal behavior, as well as a new
class of “sense-and-respond” smart drugs with application across a diverse array of disease states.

Public health relevance
Narrative We will develop technologies that exploit protein clustering to manipulate cells. This includes the development of precise light-activated probes and engineered protein systems that detect and respond to disease-causing protein aggregates. Our work will establish new paradigms for biological study and for "sense-and-respond" smart drugs that could offer new therapies for diseases including neurodegeneration, viral infections, and cancer.